Core C. External Innovative Network Core

Project Description (Core C): The objective of Core C is to provide support for ongoing development of five
external innovative research networks. Three networks continue activities initiated in the last grant cycle related
to aging in Latin America, aging in sub-Saharan Africa (SSA) and the interrelations between migration, health
and aging. Two networks are newly proposed for the next cycle: first, a Global Family Change (GFC) network
that provides overarching global research on family change and aging, thereby providing fundamental compar-
ative research informing multiple PARC themes about the implications of ongoing transformations of society’s
most fundamental building block – the family – for health, well-being and social support of older persons; second,
a network, PICANTES, that is related to two newly-proposed PARC signature themes on Cognition and Alz-
heimer’s Disease and Related Dementias (ADRD) and Health Care and Long-Term Care at Older Ages. All five
networks will enhance interdisciplinary and innovative aging research, not only at PARC but nationally and inter-
nationally, with important outreach activities that will encourage and nurture development of younger research-
ers, including from low- and middle-income countries (LMICs). Each network includes workshops, collaboration
(also pilot projects), harmonization of large-scale data collection efforts, and the development of common re-
sources. There is deliberate overlap among the five networks in terms of PARC investigators, substance, and
geographic areas of interest, leading to complementarities and synergies among PARC Networks and/or PARC
Research Themes.

Public health relevance
Project Narrative/Public Health Relevance (Core C): Interdisciplinary, co-operative research to advance knowledge in the demography and economics of aging requires an adaptive scientific infrastructure. The Popu- lation Aging Studies Center at the University of Pennsylvania, along with this Core C, provides an intellectual platform at the crucial juncture of the behavioral, social, and health sciences. The accounting and analytic frame- works of PARC, anchored in demography and health economics, provides insights to help meet the research and evidence needs to promote successful and equitable aging for individuals, and to inform effective health policy responses in aging societies, in the U.S. as well as globally.